Enhancing the research capacity of the investigators from South Dakota through the upgrade of the proteomics technology in the SD-BRIN Proteomics Core Facility.

South Dakota Biomedical Research Infrastructure Network (SD BRIN), hosted by the Sanford School of Medicine of the University of South Dakota (USD) in Vermillion, SD, is the SD component of IDeA Networks of Biomedical Research Excellence (INBRE) funded by the NIH/NIGMS Institutional Development Award (IDeA) program since 2002. This proposal has evolved from insights gained and enhancements made during the previous phase of INBRE (2015-2020) especially related to the successful implementation of the Developmental Research Project Program for advancing the research initiatives of participating faculty members from our partners at predominantly undergraduate institutions. The specific aims of the SD BRIN program have not changed from its beginning. SD BRIN Aim 1 addresses the needs of biomedical researchers at USD (the lead research intensive institution) and provides resources and support to other researchers throughout the state. SD BRIN Aim 2 addresses the needs of science faculty and undergraduate researchers at the partner predominantly undergraduate institutions and tribal colleges. Therefore, the aims of this phase of INBRE in South Dakota are to: 1) Continue to develop the research capacity of South Dakota in the area of cell biology and the control of cell growth with special emphasis on proteomics and genomics by: a) enhancing the research capacity of investigators in proteomics, b) maintaining proteomics, bioinformatics, and nucleic acid sequencing and genotyping core facilities (with professional staff) accessible to investigators throughout SD (and other IDeA states), c) offering opportunities for graduate training in proteomics, nucleic acid sequencing, and bioinformatics, and d) supporting access to online library scientific databases to all faculty and students from all SD BRIN participating institutions. 2) Develop human resources for undergraduate and graduate programs in the biomedical sciences and bioinformatics by helping to instill a culture of research and provide a pipeline for students interested in biomedical research at South Dakota’s predominantly undergraduate institutions and tribal colleges by: a) providing research support and mentoring for faculty from participating institutions, b) providing opportunities for, and understanding of, cutting-edge scientific research for students at participating institutions, c) introducing undergraduates to graduate programs and future careers in biomedical sciences and bioinformatics, and d) enhancing science education and research capabilities at tribal colleges, providing opportunities for further education and careers in science and research.

Public health relevance
PROJECT NARRATIVE SD BRIN has supported a robust network of faculty researchers throughout South Dakota in developing and maintaining new areas of biomedical research by providing expert resources in core facilities available to all researchers. In addition, SD BRIN has maintained a strong undergraduate research fellows program at predominantly undergraduate institutions (PUI) with growing research cultures to develop future biomedical researchers and to assist faculty mentors with their cutting-edge research efforts. The faculty fellows program has allowed PUI faculty to concentrate on their research efforts and use this support to increase publications and application to external funding agencies.